TELE Para DM: Telemedicine Equity for Limited English Proficient Patients with Diabetes Mellitus in the Safety Net

Project Summary/Abstract
Telemedicine (remote telephone and video health visits) is a digital health tool that can increase access to care
and improve health outcomes. Telemedicine care has been critical to maintaining healthcare access when in-
person care is disrupted, and the arrival of the Coronavirus-19 disease (COVID-19) pandemic forced the
integration of telemedicine into care almost overnight. But this is problematic for safety net health systems who
disproportionately provide care to racial/ethnic minority and Limited English Proficient (LEP) patients, who have
faced significant barriers with past digital health technology. In this K23, we will study telemedicine in the Los
Angeles County Department of Health Services (LAC DHS)— the second largest safety net in the United
States. We will focus on a particularly vulnerable population with need for frequent, interval care: patients with
diabetes mellitus (DM), specifically addressing LEP Spanish-speakers, who are 62% of the DM patients at LAC
DHS. This K23 proposal will investigate differences in factors affecting telemedicine use and explore
associated quality of diabetic care via quantitative and qualitative analyses among Spanish- and English-
speaking primary care patients (Aim 1). In partnership with the LAC DHS Virtual Care Workgroup, these
analyses will inform the tailored design of a patient coaching intervention in Spanish and in English to increase
and facilitate telemedicine use (Aim 2) and a pilot randomized controlled trial of the bilingual intervention (Aim
3). These aims will be achieved using mixed methods, implementation science, and digital health disparities
conceptual frameworks as they address the NIMHD research priority areas of developing interventions to
improve access to care for vulnerable patients and reduce health disparities. The studies are novel given the
timely focus on telemedicine implementation for vulnerable patient populations, addressing LEP patients
explicitly, as well as the proposed use of mixed methods to develop a theory-driven intervention. The proposed
studies are informed by Dr. Alejandra Casillas’ role as a primary care physician and her patient portal research
experience in diverse, urban primary care settings. Dr. Casillas’ long-term goal is to develop interventions that
reduce digital health disparities, increase health access, and improve health outcomes for racial/ethnic minority
and LEP patients. During the course of this award, Dr. Casillas will undertake didactic and experiential training
to improve knowledge and skills in three areas: (1) mixed methods in digital health disparities research, (2)
telemedicine delivery in the safety net, and (3) evaluation of pilot trial interventions in real-world clinical settings
using implementation science methods. Dr. Casillas has assembled a multi-institutional mentorship team with
the complementary expertise to ensure completion of the proposed research and training and successful
transition to independence. This K23 will position Dr. Casillas, as an early career investigator, to develop a
NIMHD-R01 for other languages and chronic disease conditions: findings could result in widespread adoption
of this model as an evidence-based intervention to augment telemedicine for vulnerable patients in the US.

Public health relevance
Project Narrative Safety net health systems care for a large proportion of vulnerable patients (racial/ethnic minority, Limited English Proficient), that that likely face barriers to Telemedicine (remote telephone and video health visits) due to a “digital divide.” When the Coronavirus-19 disease (COVID-19) pandemic abruptly prompted health systems to reduce in- person care and transition to Telemedicine, concerns surfaced as to how these patients served by safety net health systems, and especially those with chronic conditions (like diabetes mellitus, which requires frequent monitoring), would be affected. These studies will decrease digital health disparities and improve Telemedicine care access for Los Angeles safety net patients with diabetes mellitus by 1) examining differences in factors affecting Telemedicine use for LEP Spanish- and English-speaking patients, 2) using these results to design a bilingual coaching intervention to increase Telemedicine use, and 3) testing this novel intervention among Spanish- and English-speaking diabetic patients in primary care clinics.